Maintenance of cellular memory during replication

PROJECT SUMMARY
Regulation of genome access underlies development, differentiation, and response to stimuli.
Genome access in turn is determined by nucleosome packaging and modification, the “chromatin
landscape”. Static snapshots of the chromatin landscape cannot explain how stable cellular states
arise despite constant chromatin dynamics. By developing new approaches in time-resolved
structural epigenomics, we will uncover chromatin states that are invisible with current methods,
to identify the molecular determinants of cellular identity. A key pathway that determines cellular
identity during development is the polycomb pathway, an epigenetic mechanism of maintaining
cell states through gene repression. By using our novel tools to track temporal dynamics of
heterochromatin in unperturbed cells, we can map the recovery of heterochromatin after its
dilution due to replication. We will identify the factors that determine the locations where polycomb
enzymes are first recruited after replication. By tracking transcription and chromatin states across
the cell cycle, we will identify bistable states of genes where they are expressed in one phase of
the cell cycle, and they are packaged as heterochromatin in another phase of the cell cycle.
Overall, our methods will resolve how the cell cycle influences chromatin states and how
chromatin states in turn regulate the cell cycle. In summary, our approach of time-resolved-
structural genomics will uncover not only the determinants of cellular memory in fundamental
systems of mammalian development, but also provide the means to understand gene regulation
across the cell cycle.

Public health relevance
PROJECT NARRATIVE A cell’s identity is tied to how its genome is packaged. This cell type specific genome packaging is essential for normal development of the organism and is frequently disrupted in disease. This proposal will identify how a cell remembers the specific packaging of its genome every time it replicates its genome so as to maintain its identity during normal growth and how perturbation of this memory can lead to aberrant cell states.